Repurposing esomeprazole for the treatment of scleroderma

PROJECT SUMMARY
Scleroderma is a connective tissue disorder of unknown etiology affecting the skin, lungs and other visceral
organs. The disease is characterized by immune dysfunction, vascular pathology, chronic inflammation,
fibroblast overproliferation and collagen buildup. Although there are limited treatment options including
immunosuppressive drugs, these therapies only alleviate symptoms but are unable to reverse established
fibrosis and cure scleroderma. Thus, there is an opportunity to develop novel antifibrotic therapies that target
chief drivers of the disease: fibroblast overproliferation and collagen accumulation.
According to our new study, esomeprazole and its topically-formulated analog (coined Dermaprazole) might
halt progression of scleroderma. This understanding is based on our extended studies of high throughput
screening (HTS) 130,000 small molecules to discover compounds that regulate processes involved in tissue
inflammation and fibrosis. Our molecular, cell biological and in vivo data demonstrate that systemic
administration of esomeprazole inhibits lung inflammation and fibrosis by 50%. The study also showed that
esomeprazole is anti-proliferative with profound effect on fibroblast proliferation, and differentiation into
myofibroblasts. Encouraged by these, we recently reformulated esomeprazole into Dermaprazole for the
treatment of scleroderma with limited cutaneous involvement, while the systemic esomeprazole is being
developed for severe forms of the disease. Our data using human 3D skin model, dermal fibroblasts isolated
from scleroderma patients, and mouse models of scleroderma demonstrated that both forms of the drug are
effective in inhibiting fibrosis and restoring normal skin appearance. In addition, systemic esomeprazole was
found to suppress lung fibrosis secondary to skin fibrosis in a model of systemic sclerosis.
Our molecular studies indicate that esomeprazole/Dermaprazole modulate fibrosis through nuclear
translocation of the transcription factor nuclear factor erythroid 2-related factor 2 (Nrf2) to activate heme
oxygenase 1 (HO1), and suppress key extracellular matrix (ECM) proteins. Molecular studies also show that
activation of HO1 by esomeprazole involves phosphorylation of the Mitogen-Activated Protein Kinase (MAPK)
pathway. Accordingly, we plan to test our central hypothesis: esomeprazole/Dermaprazole is able to slow or
halt established fibrosis in scleroderma in MAPK/Nrf2/HO1 dependent manner. To test this, we propose the
following Specific Aims: i) Understand the mechanism(s) by which esomeprazole activates HO1 to control
inflammatory and fibrotic processes in scleroderma. In this Aim, we will evaluate the mechanistic interaction
between esomeprazole, MAPK and Nrf2 to activate HO1 and its effectors, as well as investigate whether
activation of Nrf2/HO1 by esomeprazole is required in the regulation of scleroderma fibroblast proliferation and
collagen deposition. ii) Evaluate the efficacy of esomeprazole/Dermaprazole in modulating dermal and lung
fibrosis in vivo using wildtype, Nrf2, and MAPK knockout mouse models of scleroderma.

Public health relevance
Project Narrative Scleroderma is a chronic disease of the connective tissue that is characterized by excessive accumulation of fibrous material (i.e. collagen) in the skin and ultimately in the lungs and other internal organs leading to multiple organ failure and death. Although there is no cure for this disease, research progress in animals and humans has led to better understanding of the disease process, and possible treatment options that can halt or reverse the disease are on the horizon. Recently, our research identified that an FDA-approved drug (for other disease) might be effective for scleroderma, and we now propose to conduct additional studies to develop the drug, as well as understand the mechanism(s) by which it blocks collagen accumulation in cells obtained from scleroderma patients, and in animal models of the disease.